Michigan Vision Clinician Scientist Development Program

ABSTRACT
The Michigan Vision Clinician-Scientist Development Program is designed to grow and enhance the number
and effectiveness of clinician-scientists in vision science, based on an interdisciplinary approach leveraging
collaboration across the University of Michigan. The Program encompasses the full range of scientific
inquiry from basic discovery science to clinical trials to health services, providing an opportunity for early-
career investigators to address any aspect(s) of the NEI mission and strategic plan, including areas in which
few NEI K grants are currently funded. It is designed around best practices, dedicated mentors from several
disciplines on each mentoring team, and a focus on continuous improvement and productivity. This
approach will produce vision clinician-scientists who can successfully translate cutting edge scientific
advances into enhanced patient treatment by advancing our understanding of the visual system and patient
well-being in both health and disease. We propose to maintain two scholars at a time who will also have
considerable departmental support until they achieve independent-researcher status. The impact of the
Program will be measured by the scientific achievements of the scholars and their career trajectory and
success in establishing independent contributions and programs.
!

Public health relevance
PUBLIC HEALTH RELEVANCE The Michigan Vision Clinician-Scientist Development Program develops ophthalmologists who can further our understanding of vision and its preservation and through research during their subsequent careers both contribute to new knowledge and therapies and inspire future young clinicians, researchers, and clinician- scientists. !